Writing and erasing O-GlcNAc on target proteins in the brain

WRITING AND ERASING O-GLCNAC ON TARGET PROTEINS IN THE BRAIN
PROJECT SUMMARY
O-Linked N-acetyl glucosamine (O-GlcNAc) is a nutrient sensor that dynamically modifies nuclear, cytoplasmic,
and mitochondrial proteins. Dysregulation of O-GlcNAc has been linked to disruptions in sleep and circadian
rhythm and several neurodegenerative diseases, including Alzheimer’s Disease (AD). While sleep and circadian
rhythm defects are distressing symptoms of AD and other tauopathies, sleep disturbance may be a major risk
factor for AD and is thought to accelerate its pathology. Extensive studies on the association of O-GlcNAc to AD
have led to the first clinical trials targeting O-GlcNAc for therapy. However, these inhibitors globally alter the O-
GlcNAc proteome, where a more targeted strategy may provide greater benefit. A systematic investigation of the
connection between the O-GlcNAc modification and sleep regulation and AD pathogenesis would significantly
impact the discovery of novel mechanisms to provide new avenues for targeted prevention and therapy.
O-GlcNAc is regulated by nutrient availability and the complementary activity of two enzymes: O-GlcNAc
transferase (OGT) writes the modification and O-GlcNAcase (OGA) erases it from proteins. Recently,
innovations in protein engineering and gene editing tools developed by the co-investigators have provided
access to precise tuning of O-GlcNAc on specific neurons and desired target proteins in the brain of Drosophila
model systems of sleep and AD. Here, we will capitalize on the joint expertise in the Woo Lab and Walker Lab
to facilitate the first systematic study to measure, map, and manipulate O-GlcNAc from desired target proteins
and in specific neurons in the brain to yield crucial insights to the pathogenesis of AD and novel chemical
strategies for remediation. To meet this goal, we will take a three-pronged approach. We will first systematically
examine the relationship between O-GlcNAc in specific neurons of Drosophila models of sleep and AD
pathogenesis to identify the brain regions that are most dependent on O-GlcNAc regulation. Second, we will
use a targeted writer and eraser of O-GlcNAc, developed through protein engineering, to systematically examine
the role of O-GlcNAc on selected target proteins in the brain to identify drivers and potential targets for alleviating
sleep disruptions and AD pathogenesis. Third, we will pursue the discovery of small molecules that selectively
write and erase O-GlcNAc in vitro and in vivo, which will complement our protein engineering approaches and
provide targeted alternatives to global inhibitors that are under evaluation for AD therapy in the clinic. The
successful outcome of this proposal will afford validated Drosophila models of sleep and AD with neuron-specific
manipulation of OGT and OGA or specific target proteins using target writers and erasers of O-GlcNAc, with
associated maps of O-GlcNAc proteins and sites, in addition to new and selective small molecule editors of O-
GlcNAc to enable more targeted therapeutic approaches in the long-term. Additionally, the systematic methods
and tools to connect physiological measurements to molecular function developed here will be translatable to
the study of the connection of O-GlcNAc to other neurodegenerative diseases and beyond.

Public health relevance
WRITING AND ERASING O-GLCNAC ON TARGET PROTEINS IN THE BRAIN PROJECT NARRATIVE The sugar modification O-linked N-acetyl glucosamine (O-GlcNAc) is a nutrient sensor that cells and organisms use to maintain essential biological processes. Dysregulation of O-GlcNAc is linked to disruptions in essential biological processes, including sleep and circadian rhythm, and neurodegenerative diseases like Alzheimer’s disease. In this proposal, we aim to systematically investigate precisely when and where O-GlcNAc is dysregulated in the brain using targeted O-GlcNAc writers and erasers in Drosophila models of sleep and Alzheimer’s disease.